Novel Pediatric Sepsis Criteria and Clinical Decision Support Tools

PROJECT SUMMARY/ABSTRACT
Pediatric sepsis is a major global public health problem associated with millions of deaths every year. In the
United States, 1 in every 10-15 children with sepsis or septic shock will die during their hospitalization, and
many survivors will have a lower health-related quality of life. We collaborated with an international task force
to develop and validate the novel Phoenix criteria for sepsis and septic shock in children, which were published
in two high-impact articles in JAMA and are now the reference standard for diagnosing pediatric sepsis around
the world.8,9 The criteria are based on the Phoenix Sepsis Score (PSS), which we developed using a data-
driven approach and >3.6 million patient records and include information for four organ dysfunctions. In order
to maximize the impact of the Phoenix criteria for pediatric sepsis, several knowledge gaps must be
addressed. In this study we will: evaluate the prognostic accuracy of the Phoenix sepsis criteria and the PSS
before and after the COVID-19 pandemic and in the setting of specific organisms and infectious syndromes as
well as varying vaccination status of at-risk children (SA 1); derive and validate sepsis trajectories based on the
changes in the PSS over time that can help inform clinical decision-making (SA 2); prospectively validate the
Phoenix sepsis criteria and the PSS overall and in high-risk patient subgroups (SA 3); and design and
implement generalizable clinical workflows that maximize the impact of the Phoenix sepsis criteria and PSS
trends (SA 4). We will leverage and expand our existing dataset by adding 2 new sites, 5 additional years of
data from each site, and new data elements including vaccination records. We will also conduct a prospective
study at four sites to validate the performance of the Phoenix criteria as CDS tools. We have enhanced our
accomplished investigative team by adding new sites and expertise in human-computer interaction, CDS tool
design, and pediatric hospital medicine. We expect the results of this proposal to have a powerful and
sustained impact on the science of pediatric sepsis and ultimately improve sepsis recognition, accelerate
appropriate effective treatment, decrease unnecessary treatment, and improve the outcomes of children with
sepsis around the world.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH Sepsis is a life-threatening disease caused by infection that affects many children and can frequently result in the failure of organs in the human body (for example, the lungs, heart, or kidneys). We developed new criteria to identify children with sepsis and these are now the reference standard around the world. We now propose to prospectively evaluate the new criteria as tools inside electronic health records to help clinicians take better care of children with sepsis and to identify new patterns of organ dysfunction.